Metabolic Control of Persistence in Individual Bacteria

PROJECT SUMMARY:
Cells must robustly sense, decode, and transmit information at the molecular level in order to efﬁciently
respond to changing environments, a process that typically necessitates the coordination of many reg-
ulatory elements (ie. RNA, DNA, proteins). Since a suboptimal response to environmental insults can
be enormously costly, several failsafe and protection mechanisms are in place to enhance cell survival
under harsh environments. In particular, bacteria “hedge their bets” by allowing a very small fraction
of their population to enter a non-growing state called persistence to survive enormous amounts of
antibiotics. The precise way persistence rates are controlled is currently unknown, but recent exper-
iments in E. coli suggested that imbalances in toxin/antitoxin levels that cause growth arrest during
starvation are also involved in persistence. While this hints at the existence of a fundamental link be-
tween the regulation of metabolism and persister states, it is still difﬁcult to investigate how metabolism
is involved in the active regulation of persistence rates as a bet-hedging strategy using current ap-
proaches. Our goal is to combine new advances in quantitative single-cell microscopy and synthetic
biology with mathematical modeling to investigate three core aspects of persistence and bet-hedging
in bacteria. First, we will investigate how persistence is controlled by quantifying the metabolite proﬁle
of cells under environmental perturbations and tracking energy levels during persister pathogenesis
using quantitative single-cell microscopy. Second, we will investigate how persistence is activated
by studying how metabolic network perturbations trigger persistence using high-throughput CRISPR
interference assays. Third, we will investigate how cells recover from a persister state by targeting
metabolic pathways to tune the rates of persistence and developing data-driven metabolic models
of antibiotic tolerance. Over the next ﬁve years, these studies will unravel the interconnected relation-
ships between growth, metabolism and environmental stress, and they will help uncover how metabolic
networks regulate persistence as a bet-hedging strategy in bacteria. These efforts can help us better
understand and hopefully control persistence, which is critical in our ongoing ﬁght against antimicrobial
resistance.

Public health relevance
PROJECT NARRATIVE: Antibiotic resistance is a growing problem worldwide but antibiotic discovery has stalled over the past decades. It is challenging to develop new antimicrobials because cell-to- cell variability can diminish the efﬁcacy of antibiotics and we currently lack the tools necessary to study antibiotic action at the single-cell level. We are developing an experimental platform to study mechanisms of antibiotic tolerance in single cells, which may help ﬁnd ways to potentiate existing therapies and discover new antibiotic targets.